The role of repressive nuclear bodies in latent herpes simplex virus infection

PROJECT SUMMARY/ABSTRACT Herpes simplex virus type 1 (HSV-1) is a ubiquitous human pathogen that is present in up to 90% of the world’s population. HSV-1 persists for life in the form of a latent infection in the peripheral ganglia that innervate the head and neck. Reactivation of HSV-1 from latent infection is associated with significant morbidity, including herpetic eye disease which can manifest as conjunctivitis, blepharitis or corneal epithelial and stromal keratitis. Recurrent ocular reactivation of the virus can result in recurrent herpetic keratitis, which remains the leading cause of infectious blindness in the developed world. Therefore, there is a need to understand how the virus remains latent in neurons to ultimately prevent reactivation and recurrent infection. During latency, the viral genome is associated with repressive nuclear structures and is assembled into heterochromatin. The role of cellular heterochromatin-associated proteins in maintaining HSV-1 latency is not known. I have identified one cellular protein, ATRX, that is essential for maintaining HSV-1 latency. In Aim 1 of this proposal, I will utilize a novel primary neuronal model of HSV-1 latency that permits the establishment of a latent infection in peripheral neurons cultured in microfluidic chambers. I will test the hypothesis that ATRX is the key cellular protein involved in preserving HSV-1 latency and examine how ATRX maintains heterochromatin-based gene silencing. In addition, I will utilize an ocular model of infection to understand the effects of ATRX depletion in vivo. These studies will provide mechanistic insights into the contribution of heterochromatin-based silencing in maintaining HSV-1 latency and preventing recurrent reactivation. There is considerable heterogeneity at the neuronal level in the co-localization of viral genomes with different nuclear domains, likely resulting in different types of latency that are more or less susceptible to reactivation. I have found that exposure of neurons to type I interferon (IFN) results in the formation of repressive PML- nuclear bodies, as well as a more restricted form of latency than that established in the absence of type I IFN. Therefore, in Aim 2 of this proposal, I will investigate how PML-nuclear bodies form in response to type I IFN and examine the contribution of PML-nuclear bodies in compacting latent HSV-1 genomes and making them refractory to reactivation. The ultimate goal of these aims is to understand how to preserve long-term HSV-1 latency through either maintaining ATRX association with viral genomes and/or promoting compaction of HSV- 1 genomes in repressive PML-nuclear bodies.

Public health relevance
PROJECT NARRATIVE Herpes simplex virus 1 (HSV-1) establishes a latent infection in peripheral neurons and can periodically reactivate to cause disease. Ocular HSV-1 infections cause over 50,000 new and recurrent cases of herpes stromal keratitis each year in the U.S. alone and remain the leading cause of infectious blindness in the Western world. I am proposing to study the role of specific cellular heterochromatin-associated proteins and nuclear bodies in the establishment and maintenance of HSV-1 latency to facilitate the development of antiviral therapeutics that target the latent stage of infection to prevent reactivation.